University of Louisville Biomedical Integrative Opportunity for Mentored Experience Development -PREP (UL-BIOMED-PREP)

Abstract
There is strong evidence for a significant race and gender gap in academia, and first generation graduates face
inequity in becoming tenured faculty. Moreover, Kentucky (KY) is a state with a large economically
disadvantaged population, including first generation/rural graduates, who are underrepresented in STEM fields.
A highly effective approach to remediating the paucity of diversity in STEM is to provide underrepresented
students with the tools they need to apply to and succeed in graduate school. The goal of the University of
Louisville (UofL) Biomedical Integrative Opportunity for Mentored Experience Development-PREP (UL-BIOMED-
PREP) is to train the next generation of underrepresented scientists in STEM fields, including Medicine,
Dentistry, Arts and Sciences, and Engineering. UL-BIOMED-PREP is a unique integrated education program
among these four schools; it will provide students from Kentucky and surrounding areas who are
underrepresented in the STEM fields with extensive mentored development and research opportunities in these
disciplines with access to a large array of scientific projects, tailored courses designed to develop skills that will
prepare students to successfully apply to and complete graduate school, and cohort-building activities geared
toward building resiliency and developing critical thinking and life-long learning skills necessary for becoming a
scientific leader. There are currently no PREP programs in Kentucky and this initiative aligns very well with the
current strategic plan of UofL to pursue inclusiveness in education. Seven to eight UL-BIOMED-PREP scholars
will be recruited from the UofL and regional programs/colleges geared to facilitate achievement of
underrepresented students in STEM, with an emphasis on African American and Latino, first generation
graduates and economically underserved students from both rural and urban areas in KY. A personal
development plan will be developed for each scholar at the start of the program based on individual skills and
needs, that will be re-evaluated regularly. An experienced research mentor will be chosen at the end of two
laboratory rotations, a research committee assigned to evaluate monthly progress, and a student mentor
assigned to provide personalized advising. UL-BIOMED-PREP scholars will present any program outcome
regularly at regional/national meetings and via social media. In addition to courses designed to aid in the
preparation of graduate school applications and complete graduate school, monthly career development
activities will help foster an inclusive community, networking and help scholars develop confidence and a growth
mindset. Internal and External Advisory Committees will regularly evaluate the program and provide ongoing
feedback that will be used to improve the program. Upon program completion, UL-BIOMED-PREP scholars will
possess improved research and analytical skills, a better understanding of graduate school expectations, and
the resiliency and self-confidence to handle the challenging demands of graduate school. Our goal is to reach
the target of 85% of UL-BIOMED-PREP scholars being admitted and completing graduate school.

Public health relevance
Project Narrative Because of the Kentucky's large economically disadvantaged population and the race and gender gap in academia, it is imperative to provide underrepresented students in Kentucky with the tools they will need to apply and succeed in graduate school. The overall objective of this research education program is to recruit and train the next generation of underrepresented scientists in the STEM fields by developing a unique integrated education program among faculty of the Medical, Dental, Arts and Sciences, and Engineering schools at the University of Louisville. This program will provide students from Kentucky and surrounding area underrepresented in STEM extensive research training in various biomedical disciplines, and development of various skills necessary to become successful scientists and of a strong sense of belonging in science.